Implementing a culturally appropriate digital health intervention to reduce tobacco-related cancer disparities among Hispanic/Latinx Communities

ABSTRACT
Smoking is responsible for 30% of all cancer deaths and 80% of lung cancer deaths in the United States.
Hispanic/Latinx (“H/L”) communities experience profound tobacco-related inequities. Among U.S adults who
smoke, H/L are less likely to receive advice to quit by health professionals and to use smoking cessation
counseling and/or medication, compared to other racial/ethnic groups, despite their high interest in quitting.
Moreover, high stress (related to acculturation, immigration, discrimination, and other factors) is a critical barrier
to smoking cessation among H/L. There is an urgent need to increase access to and use of culturally appropriate
smoking cessation interventions that address barriers to cessation for H/L communities. Digital health
interventions are a cost-effective way to increase access to smoking cessation treatment among H/L.
Mindfulness-based interventions also show promise for promoting psychosocial functioning and smoking
cessation in diverse populations including H/L. However, cultural adaptations, as well as strategies for their
successful implementation in healthcare and community settings, are needed to increase intervention impact
and reach. This project will culturally and linguistically adapt an evidence-based digital health smoking cessation
intervention, iQuit Mindfully, for H/L. Using implementation mapping, we will engage in a systematic process for
gathering in-depth, iterative community feedback to adapt and optimize the intervention, and to guide
implementation practices and maintenance of this intervention in real world settings. Specific aims are to: 1)
Linguistically and culturally adapt iQuit Mindfully for H/L adults; 2) Refine and evaluate the feasibility,
acceptability, and implementation processes of the adapted intervention through iterative testing; and 3) Finalize
and test implementation protocols for deploying the intervention in healthcare and community settings. Aim 1 will
leverage formative work with community partners and key stakeholders. Aim 2 will involve three usability/pilot
trials to refine the intervention and implementation processes based on user-centered design and ongoing
community feedback. In Aim 3, we will partner with three other Cancer Prevention and Control Research Network
(CPCRN) collaborating centers to refine, test, and finalize the implementation protocol. A culturally adapted text
messaging intervention could be a scalable, cost-effective way to implement smoking cessation treatment to
reduce cancer health inequities in H/L. The GSU CPCRN Collaborating Center will engage in large-scale network
efforts to increase the impact of this project and others on cancer health equity.

Public health relevance
NARRATIVE Hispanic/Latinx (“H/L”) communities experience unique barriers to smoking cessation, contributing to cancer- related inequities. This project will culturally and linguistically adapt an evidence-based digital health smoking cessation intervention for H/L, leveraging community engagement and implementation science to optimize the benefits and reach of the intervention through healthcare and community settings. The Georgia State University Cancer Prevention and Control Research Network (CPCRN) Collaborating Center will engage in large-scale network efforts to increase the impact of this project and others on cancer health equity.